SENTENCE PREDICTION IN DEVELOPMENTAL LANGUAGE DISORDER

PROJECT SUMMARY/ABSTRACT
Millions of children – 7-12% of the school-age population – have developmental language disorder (DLD), a
disorder that affects language learning, comprehension, and use. These children have difficulty with sentence
production and comprehension at every stage of their development. These difficulties have major implications
for the educational attainment of children with DLD compared to children with typical development (TD). Children
with TD and adults make rapid predictions of upcoming words following verbs (e.g., predicting the patient in The
dog eats the bone or the agent in The bone is eaten by the dog). Extensive work in children and adults indicates
that prediction facilitates sentence comprehension by inducing a state of preparedness and contributes to
language development by tuning the language system to the input. Children with DLD have a poorer ability
to make sentence predictions, which may compound and result in sentence-comprehension deficits.
Prior work on prediction deficits in DLD has focused on broad sentence characteristics like typicality or broad
participant characteristics like vocabulary test scores. However, studies with typical individuals have identified
more specific sentence- and participant-level contributors to sentence prediction. These factors have not been
systematically explored in children with DLD. We explore three separate hypotheses concerning factors that
affect prediction in DLD. First, sentence- and participant-level properties affect prediction in children with DLD.
Second, children with DLD lack robust representations of the underlying linguistic knowledge needed to predict,
particularly abstract semantic features. Third, children with DLD have differences in event processing that relate
to sentence prediction skill. We investigate these hypotheses in 5-7-year-old school-age children with DLD
across three Aims. Aim 1: Measure the effect of sentence- and participant-level properties on sentence
prediction. We will measure two participant-level cognitive factors (processing speed, verbal working memory)
and their effect on prediction of agents and patients in sentences varying across two properties (syntactic
complexity, semantic competition). Aim 2: Measure linguistic knowledge that underlies sentence
prediction. We will measure knowledge of agent-verb and verb-patient cooccurrences (e.g., dog-bite, eat-apple)
and knowledge of verb-specific semantic features (e.g., throw-<round object>). Aim 3: Measure event-
processing skills that underlie sentence prediction. We will measure how children with DLD categorize and
attend to agents/patients in visual scenes. Impact: This project has the promise to be highly impactful. First, it
bridges disparate literatures on language processing in adults, children with TD, and children with DLD, providing
clarity about predictive processing in DLD. Second, it may influence intervention approaches by identifying areas
of strength and need in children with DLD. Third, it sets the stage for larger-scale longitudinal work examining
effects of early prediction ability, language knowledge, and event processing on later sentence comprehension.

Public health relevance
PROJECT NARRATIVE Children with developmental language disorder (DLD) have difficulties with sentence prediction, syntactic knowledge, semantic knowledge, and processing factors, but these difficulties have not yet been examined together in a systematic way. The results of this project will contribute to theoretical accounts of syntax-semantic interactions and event processing strategies in DLD and provide guidance for interventions focused on sentence comprehension and vocabulary knowledge to improve language-related health and educational outcomes.